HEALTHY AGING AND SENILE DEMENTIA

This unit will continue to provide administration and statistical analysis for the longitudinal interdisciplinary program project which compares healthy aging and senile dementia/Alzheimer type.